Administrative Core

Administrative Core - Abstract
The UNC Breast Cancer SPORE Administrative Core has supported the infrastructure, planning, and evaluation of the UNC Breast SPORE since 1992. The Administrative Core and its co-leaders Drs. Perou, Carey, and Earp are responsible for the institutional long-range plans and resource commitments of the Cancer Center’s largest translational portfolio. The functions of the Administrative Core include organizing weekly leadership meetings, monthly SPORE faculty scientific meeting, quarterly Executive Committee and Advocate meetings, and the yearly External Advisory Board. The Core collates formal reports to evaluate the progress of all SPORE elements, projects, pilots and career development and mentorship. The Core facilitates interactions with the NCI SPORE program and other NCI SPOREs, as well as with multiple breast cancer research collaborations. The Core manages the Career Enhancement Program under Dr. Carey’s leadership, including conducting external and internal searches for talented potential SPORE investigators. The Core also manages the Developmental Research Program (DRP) with Dr. Earp as PI, including organizing the pilot project competition and facilitating funding and evaluation of DRP projects. The Core follows all pertinent data including trials and accrual. Marjory Charlot MD, MPH, an active oncologist and UNC Lineberger Assistant Director of Community Outreach and Engagement has an important role in the Administrative Core to monitor and stimulate accrual to population and therapeutic trials. The Core manages the finances of the SPORE including the substantial institutional commitment to CBCS, projects, infrastructure, recruitment, CAR T trial and breast cancer geriatric oncology efforts. The total commitment will exceed $10M over the next 5 years. Through these activities, the Administrative Core evaluates the finances, progress, and metrics in support of an exceptional team of breast cancer translational researchers as they explore, address, and analyze translational advances from multiple angles, attempt to understand all facets and the potential of the immune system in therapy and resistance, use genomic analysis to better understand prognosis and prediction, advance new technology, and develop junior faculty into translational research leaders.